Fibrotic remodeling of lymph nodes disrupts T cell function in fibrosis and cancer

Project Summary/Abstract
Fibrosis is a hallmark of cancer that promotes proliferation, metastasis, and immune evasion by altering the
tumor stroma which accounts for up to 90% of tumor mass. In fibrosis, pathogenic departure from homeostasis
results in the excessive deposition of extracellular matrix (ECM) by myofibroblasts, creating discrete regions of
non-resolving wound repair. These regions of fibrotic ECM become dominant regulators of cell phenotype,
providing both biochemical (i.e. ECM composition and soluble factors) and biophysical (i.e. mechanical forces
and material properties) cues to promote tumor progression and restrict immune cell infiltration. Soluble factors
within the interstitial space of these fibrotic organs drain into surrounding lymph nodes (LNs) and induce fibrotic
remodeling in the LN, a common sign of poor prognosis in cancer and other fibrotic pathologies. LNs have a
distinct microenvironment known as the conduit system, which traffics antigens and serves as a migratory
scaffold for lymphocytes. In health, its organization facilitates interactions between T cells and antigen presenting
cells to ensure robust immune activation in response to cancer, pathogens, and injury. Fibroblastic reticular cells
(FRCs) construct and ensheath this collagenous network and produce cytokines that promote T cell survival and
homeostasis. Disruption of this ECM network leads to T cell dysregulation and depletion, implicating lymph node
fibrosis in disease progression. The mechanisms of fibrotic initiation in the LN and the effect of LN fibrosis in T
cell function is poorly understood, yet represent an attractive therapeutic opportunity. In other tissues, fibrotic
remodeling mechanically stiffens the microenvironment, initiating integrin-mediated signaling cascades. I
hypothesize that similar mechanisms drive LN fibrosis by FRCs, and seek to explore how remodeling of the LN
microenvironment affects development of T cell responses in fibrosis and cancer.
The first aim of this proposal (F99 phase) evaluates whether integrin signaling drives LN fibrosis by promoting
FRC-to-myofibroblast differentiation. This will be accomplished in part by analyzing LNs from Idiopathic
Pulmonary Fibrosis and melanoma patients with advanced mechanobiological (atomic force microscopy) and
spatial-omic imaging (CODEX) methods to measure stiffness, ECM content, and FRC/T cell phenotypes. The
knowledge and skills learned in Aim 1 are then applied in Aim 2 (K00 phase) to study the impact of fibrosis in
tumor draining LNs on anti-tumor T cell responses in murine models of melanoma.

Public health relevance
Project Narrative Lymph nodes are a primary site for immune activation against malignancy, but are also a frequent site of metastasis, the leading cause of cancer related death. During cancer progression the extracellular matrix (ECM) scaffold that organizes immune cell response in the lymph node is altered, and ECM alterations such as lymph node fibrosis are associated with worse prognosis. This study focuses on investigating αvβ3 integrin as a target to reverse ECM remodeling in the lymph node during the F99 phase and whether targeting similar pathways enhance the effectiveness of immunotherapy during the K00 phase.